Nrf2 and the expansion and preservation of beta cell mass

Summary
All major forms of diabetes result from a deficit of functional β-cells. Thus, it is critically important to develop
therapies to preserve and expand β-cell mass. We have demonstrated that Nrf2, the master transcriptional
regulator of antioxidant enzymes, plays a significant role in modulating β-cell mass. Nrf2 protects -cells from
oxidative stress, but the mechanisms, external cues, and signaling pathways that regulate Nrf2 are incompletely
understood. We recently found that Nrf2 activation expands cell mass, preserves -cell identity and insulin
content, and improves glucose tolerance after a high caloric diet. Treatments that increase cAMP through G
protein-coupled receptors (GPCRs; for example, agonism of Gs-linked EP4 prostaglandin E2 (PGE2) receptors
or the GLP-1 receptor (GLP-1R), or antagonism of Gi-linked EP3 PGE2 receptors), also lead to increased β-cell
proliferation, retention of β-cell identity and protection of β-cell mass after challenge with cytokines or glucose
toxicity. Importantly for this proposal, our published and preliminary data suggest that Nrf2 is activated by and
necessary for the effects of PGE2 receptor modulation and for the effects mediated by GLP-1 receptor agonists.
In this proposal our assembled team is uniquely positioned to explore the relationship between Nrf2 activation
and other pathways known to protect β-cells from oxidative stress, retain β-cell identity, and promote adaptive
β-cell expansion. We hypothesize that the Nrf2 pathway is a common junction between eicosanoid and incretin
signaling and thus is a critical nexus of β-cell preservation, identity, adaptation, and function; therefore, Nrf2 is
crucial for these agents to improve functional β-cell mass in diabetes. Specific Aim 1 will test the hypothesis that
activation of Nrf2 and EP3 antagonism and/or GLP-1R or EP4 agonism work together to enhance β-cell
proliferation and β-cell protection from oxidative stress. Specific Aim 2 Identify β-cell-specific Nrf2 targets and
characterize the transcriptome and chromatin landscape of Nrf2 activation, EP3 antagonism, and/or GLP-1R or
EP4 agonism as these treatments preserve β-cell mass. Specific Aim 3 Explore the in vivo therapeutic potential
of combined Nrf2 activation with EP receptor modulation and/or GLP-1R agonism. These studies will provide
key mechanistic information, identify new β-cell-specific gene targets, and test the therapeutic potential of three
attractive and inter-related pathways that will be of great value to the field for the therapeutic preservation and
expansion of functional β-cell mass highly needed in diabetes.

Public health relevance
Project Narrative In this proposal we will explore the mechanisms by which Nrf2 preserves -cell mass and acts as a common node for the eicosanoid and incretin signaling pathways, and we will test the exciting therapeutic potential of activating combinations of these pathways to treat diabetes. These studies are directly relevant to the many millions of patients with diabetes worldwide who will benefit from the knowledge generated with these studies that could lead to the development of novel therapeutic strategies to treat this disease.